Virulence gene regulators of enteric bacterial pathogens: Determining the structural and functional mechanisms of small molecule and polypeptide inhibitors

Virulence gene regulators of enteric bacterial pathogens: Determining the structural and functional
mechanisms of small molecule and polypeptide inhibitors
Summary:
The AraC/XylS family is one of the largest families of bacterial transcription factors with ~16K members
distributed amongst 81% of sequenced bacterial species. Family members are present in pathogenic genera
including Acinetobacter, Escherichia, Klebsiella, Legionella, Pseudomonas, Salmonella, Shigella, Vibrio, and
Yersinia. The regulon of any given family member typically encompasses one of three categories: metabolism,
stress response, or pathogenesis. Those involved in metabolism or stress response often have well
characterized ligands. For example, AraC regulates the expression of genes involved in arabinose metabolism
and its activity is modulated by arabinose. In contrast, small molecule ligands have not been identified for the
vast majority of virulence regulators within the AraC family (hereafter referred to as AraC-VRs), which has led
to the commonly held belief that the AraC-VR branch of the family has lost the ability to respond to ligands.
Published work by us and others –and our preliminary studies– suggest that this assumption is incorrect.
Additionally, a large family of endogenously encoded polypeptides, ANRs for AraC negative regulators, have
been discovered that inhibit AraC-VRs though an unknown mechanism.
The long-term goal of this project is to define the structural and molecular mechanisms underlying virulence
gene regulation. The specific objectives of this proposal are to determine how AraC family members including
Rns, a primary virulence regulator in enterotoxigenic E. coli (ETEC), are inhibited by 1) small molecule fatty
acids and 2) AraC negative regulators (ANRs). Our central hypothesis is that Rns must dimerize in order to
bind to DNA and regulate transcription and that these inhibitors block this by distinct mechanisms. The
motivating rationale for these studies is that they will identify the molecular and structural requirements for
inhibiting virulence gene expression, and will be tested by three specific aims: 1) Determine the structural
mechanism by which ligand binding and dimerization regulates Rns activity; 2) Test our hypothesis that the
Rns homolog RegA is regulated in the same manner; 3) Determine the mechanism by which ANRs inhibit Rns
activity, and clarify if this is distinct from the inhibitory mechanism of small molecule fatty acids.
This project is innovative in that the basic molecular mechanisms by which these proteins are regulated are not
understood. Our multidisciplinary team, with expertise in microbiology, biochemistry, and structural biology, is
uniquely positioned to undertake the proposed studies to determine these mechanisms. This research is
significant, not only because it will answer outstanding questions of how AraC proteins function in enteric
pathogens, but because we expect to demonstrate that AraC family proteins from a wide variety of enteric
pathogens share a common mechanism of being inhibited by fatty acids. This will open up new possibilities for
therapeutic strategies to combat global mortality and morbidity.

Public health relevance
Project Narrative: Bacterial pathogens adapt their strategies by sensing and adapting to signals from the environment within the human host. This study will reveal the molecular characteristics of those signals and the mechanisms of pathogen adaptation and response.